Network Models for Metabolomics

Summary
Our proposal describes network based approaches for the analysis of data from metabolomics studies. The speciﬁc
aims of this proposal include:
Aim 1: Variable selection methods in metabolomics studies, incorporating metabolite dependence and external
pathway information. We propose a Bayesian variable selection approach to incorporate both a partially observed,
external pathway network and a data-driven partial correlation network.
Aim 2: Models to identify differential metabolic networks that characterize groups within a study, and addi-
tionally detect subcomponents with group-speciﬁc associations with an outcome. When metabolic networks
differ according to groups, exposure levels (e.g. treatment) or other factors, our proposed framework will provide an
approach to identify group-speciﬁc networks as well as subcomponents that are associated with outcome, in a possibly
group-speciﬁc manner.
Aim 3: Methods to identify metabolite subnetworks that collectively mediate the relationship between an ex-
posure and an outcome. We propose a two-phase analysis framework involving (1) Detection of metabolite subnet-
works enriched for association with the outcome; and (2) Estimation of the magnitude of the indirect effects mediated
by metabolite subnetworks.
Application to testing clinical hypotheses in the WHI, NHS and HAPO metabolomics studies: Using methods
developed in Aims 1, we will identify metabolites and modules associated with risk of stroke in the NHS and maternal
metabolomic markers of newborn adiposity in the HAPO study. Using methods in Aim 2, in the WHI, we will identify
metabolic subnetworks that change due to initiation of hormone therapy (estrogen, progestin plus estrogen, placebo)
within age groups, with treatment/age dependent modules associated with subsequent risk of CHD; in the HAPO
study, detect maternal metabolite networks that differ between mothers of boys versus mothers of girls and sex-speciﬁc
subcomponents that inform sex-related differences in newborn body composition related to maternal glycemia during
pregnancy. Aim 3 methods will be applied to detect metabolite subnetworks that potentially mediate the association of
exposures such as dietary score and risk of CHD in the WHI; and maternal glucose during pregnancy and newborn
adiposity in HAPO.
IMPACT: Signiﬁcant federal investment has been made into research of the metabolomic underpinnings of complex
disorders, such as through the NIH's Common Fund Metabolomics program. Our interdisciplinary team proposes to
develop and apply new statistical models to effectively mine rapidly growing metabolomics data sources to elucidate the
etiology of complex disorders such as CHD, stroke and maternal glycemia during pregnancy as it relates to newborn
size at birth.

Public health relevance
Narrative Signiﬁcant federal investment has been made into the research of the metabolomic underpinnings of complex disorders, including the NIH's Common Fund Metabolomics program. Our focus is on the development and application of new statistical and network models to effectively analyze metabolomic and clinical data. The proposed research builds on an existing, productive collaboration between interdisciplinary scientists and is ﬁrmly rooted in the investigation of clinically relevant hypotheses to elucidate the etiology of complex disorders such as cardiovascular disease and maternal glycemia during pregnancy.